Targeting Drug-Resistant Castration Resistant Prostate Cancer via LIMK2

Abstract
Prostate cancer (PCa) is the second most common cause of cancer-related death in men in the US, primarily
due to the emergence of castration resistant prostate cancer (CRPC). Our long-term goal is to identify effective
drug targets and develop small molecule inhibitors for CRPC. Our objective here is to determine the potential
of LIMK2 kinase as a clinical target, and LI-11 (a highly potent and specific LIMK2 inhibitor) as a drug
candidate for enzalutamide-resistant CRPC. The central hypothesis is that LIMK2 is a disease-specific target
that is upregulated upon castration and promotes CRPC emergence, progression and enzalutamide resistance
via upregulation of AR, ARV7 and PI3K pathways. We show that LIMK2 is highly expressed in CRPC tissues,
but minimally expressed in normal prostates. Inducible knockdown or specific inhibition of LIMK2 fully reverses
CRPC tumorigenesis in vivo, strongly supporting LIMK2 as a potential clinical target. Equally importantly, LI-11
synergistically enhances the efficacy of enzalutamide in CRPC cells. At a molecular level, LI-11 simultaneously
depletes AR and ARV7, and inhibits PI3K signaling. Thus, LIMK2 targets three critical nodes driving CRPC
progression including enzalutamide-resistance in tandem. We propose the following three specific aims: (1)
Dissect the molecular mechanisms by which LIMK2 activates AR signaling in CRPC. (2) Investigate the
molecular mechanism of LIMK2-mediated activation of PI3K pathway in CRPC. (3) Determine the potential of
LIMK2 as a clinical target in enzalutamide-resistant CRPC and PDX models using LI-11 in vivo.
Innovation: LIMK2 is a potential clinical target for PCa. The hypothesis was formulated based on an innovative
chemical screen, which led to the discovery of several direct substrates of LIMK2. These LIMK2 substrates
unlocked a powerful mechanism for therapeutic targeting of AR, ARV7 and PI3K pathways in tandem in CRPC.
We have developed a highly potent and specific LIMK2 inhibitor (LI-11) that fully reverses tumorigenesis in vivo
with no detectable toxicity. LI-11 will be used for preclinical validation of LIMK2 as a therapeutic target in cells
and in vivo. LuCaP PDX models with variable LIMK2 levels will be used to determine whether LIMK2 levels
correlate with LI-11 and enzalutamide sensitivity in vivo. Several CRISPR engineered cell lines will be utilized
for genetic interrogation of LIMK2’s role in CRPC pathogenesis.
Significance: Successful completion of the proposed studies will provide a new strategy to simultaneously
inhibit three critical pathways via LIMK2, which lead to CRPC progression and enzalutamide-resistance. In vivo
studies will reveal the potential of LIMK2 as a clinical target and LI-11 as a candidate drug. PDX mouse models
with different LIMK2 levels will further uncover whether LIMK2 levels can serve as a novel predictive marker for
determining the efficacy of CRPC therapy. The data further indicate that targeting LIMK2 could prevent the
emergence of CRPC following androgen deprivation therapy. Finally, the validation of LIMK2 as a therapeutic
target in CRPC may improve the odds of treating other aggressive cancers, where LIMK2 is upregulated.

Public health relevance
Project Narrative The goal is to identify and validate molecular targeted therapies and small molecule inhibitor for treating patients with highly aggressive prostate cancer with minimal collateral toxicity. Our research is also expected to assist in designing interventions for patients susceptible to developing prostate tumors following castration therapy.